XIRP2 in Stereocilia F-Actin Repair

ABSTRACT
Approximately one in seven adults in the United States (37.5 million) experience some degree of hearing loss,
making it the third most common health condition among American adults. Hearing relies on the precise function
of auditory hair cells, which possess specialized stereocilia that deflect in response to sound, activating
mechanically-gated ion channels essential for mechanotransduction. Because mammalian auditory hair cells
cannot regenerate, damage to stereocilia can lead to progressive hearing loss. Understanding endogenous
mechanisms of damage repair is critical for identifying potential avenues for treating hearing loss. Recent findings
from our lab reveal that noise exposure induces gaps in stereocilia F-actin, which are subsequently repaired,
suggesting the presence of an active repair mechanism. A critical question remains: how do hair cells sense and
repair F-actin damage, and how does this process prevent hearing loss? The actin-associated protein XIRP2 is
highly enriched in hair cell stereocilia and accumulates at F-actin damage sites. Our lab has shown that Xirp2
knockout mice exhibit impaired stereocilia repair and progressive hearing loss, implicating XIRP2 in actin repair
and hearing maintenance. I hypothesize that XIRP2 detects and mediates the repair of stereocilia F-actin
damage, and this process is regulated by upstream signaling pathways. To test this hypothesis, I propose two
complementary aims. Aim 1 investigates the mechanism by which XIRP2 detects F-actin damage in a
heterologous cell system. Using laser ablation to induce actin damage, I will identify the protein domain
responsible for XIRP2 recruitment and explore the regulation of its activation. Aim 2 examines the role of XIRP2
in hair cells using a transgenic mouse model enabling live imaging of endogenous XIRP2. I will determine
XIRP2’s baseline dynamics, its recruitment to F-actin lesions, and the protein domain responsible for its
recruitment in hair cells. By elucidating the upstream regulation of XIRP2 and its role in actin repair, this work
will provide key insights into the molecular pathways enabling hair cells to respond to damage, offering potential
therapeutic targets to mitigate progressive hearing loss.

Public health relevance
PROJECT NARRATIVE This proposal outlines an endogenous mechanism by which hair cells detect and repair damage to their filamentous actin (F-actin) structures, a process crucial for maintaining hearing. The data generated from these experiments will provide fundamental insights into the repair mechanisms in mature hair cells. Understanding this process could inform potential therapeutic strategies for preventing progressive hearing loss.